Pharmacokinetics and modeling of betamethasone therapy in threatened preterm birth

? DESCRIPTION (provided by applicant): The purpose and long-term goal of this application is to optimize maternal and neonatal outcomes by individualizing antenatal corticosteroid therapy. Focusing on betamethasone (BMZ), we hypothesize that by better understanding the disposition and action of antenatal corticosteroids, we will be able to develop an individualized dosing strategy for BMZ that will improve neonatal outcomes and safety. The objective of this study is to fully interrogate the disposition, efficacy, and safety of BMZ to improve its therapeutic use an resolve efficacy discrepancies. We will accomplish this through two specific aims: 1) We will characterize the pharmacokinetics and the pharmacogenetic variations that may lead to altered neonatal outcomes in response to antenatal corticosteroids; and 2) We will develop a novel personalized therapeutic model aimed at reducing disparities and optimizing neonatal outcomes. A collaborative multidisciplinary research team with the necessary expertise required to complete these studies is in place. To accomplish these aims we will utilize our successful subject recruitment infrastructure to recruit a cohort of women presenting for BMZ therapy due to anticipated preterm birth. The research will generate data aimed at maximizing the neonatal benefits from BMZ. The individualized therapeutic model created then can be validated and tested in a clinical trial. This individualized approach to treatment would have a significant impact on the therapy of a large number of babies born prematurely who may be inadequately treated by the current dosing standard. The proposal is innovative in that it would be one of the first obstetric pharmacokinetic/pharmacodynamic/pharmacogenetic modeling studies to address outcome disparities from antenatal corticosteroids and would combine the genetic data with pharmacokinetic measurements to allow better understanding of the drug response in these patients. This program of research also has great potential to serve as a template for more informed individualized pharmacotherapy investigations for a wide range of pregnancy conditions.

Public health relevance
PUBLIC HEALTH RELEVANCE: Utilizing pharmacokinetic analysis, genetic interrogation, and sophisticated therapeutic modeling, this proposal aims to explore and improve antenatal corticosteroid therapy. This research is relevant to public health in that it will lead to the development of an individualized model for antenatal corticosteroid therapy that may serve to optimize neonatal outcomes and potentially eliminate preterm infant respiratory outcome disparities.